DEVELOPMENT OF SCIENCE EDUCATION MATERIALS

The purpose of this contract is to develop accurate, science based print and video materials for improving understanding of science, particularly as it relates to drug abuse, among second and third grade students and their parents and teachers. The materials to be developed include an eight to ten minute video, student print materials, a teacher's guide, and a parent's guide.